Carol Act Supplement to Data-driven optimization of therapy for heart failure

ABSTRACT
This proposal is submitted in response to NOT-HL-23-078 “Administrative supplements to encourage research
in valvular heart disease” and seeks 12 months of additional support for HL163977, Data-driven optimization of
therapy for heart failure. The parent R01 is active until 2026.
The overarching goal of HL163977 is to develop a computer model of the heart that can be used to test
therapeutic strategies and optimize treatments for patients who have heart failure. Aim 1 develops a system
called MyoVent as a test-bed for implementing baroreflex control and myocardial growth. Aims 2 and 3 use the
techniques developed with MyoVent and deploy them in a more sophisticated 3D framework called MyoFE to
create patient-specific personalized models.
The team has made rapid progress and Aim 1 is now mostly complete. The breakthrough was accomplished by
developing algorithms that modulate concentric (wall thickening / thinning) and eccentric (chamber dilation /
constriction) growth in response to physiologic signals. Specifically, the model assumes that hearts grow
concentrically to stabilize the intracellular ATP concentration while eccentric growth is sensitive to the passive
intracellular stress sensed by titin filaments. These growth laws reproduce the patterns of cardiac growth
observed in clinically-relevant conditions including hypertension, exercise, and destabilization of the myosin
super-relaxed state.
This supplement will extend the simulations to valvular heart disease. The objective is focused. The team will
test whether the growth laws predict the patterns of eccentric and concentric growth observed clinically in patients
with mitral valve insufficiency (including mitral valve prolapse) and stenosis, and aortic valve insufficiency and
stenosis. This will be accomplished in a single year by a highly-qualified and experienced post-doc who will work
under the supervision of the contact PI.

Public health relevance
NARRATIVE This project develops computer programs that can predict how a patient's heart will grow and adapt when valves become diseased and either restrict flow or allow blood to leak backwards. The long-term goal is to create software that cardiologists can use to optimize therapies for patients who have valvular heart failure.